FDA FERN Cooperative Agreement Program - Nebraska Department of Agriculture

Project Summary FOA- FDA-FD-15-021 The Nebraska Dept. of Agriculture Residue/FERN-Chemical laboratory wishes to continue to be a valued member of the FDA/FERN/Chemical network. Six years of participation has demonstrated the Residue Laboratory's excellence, reliability, and dependability. Nebraska will continue to be a valuable member to assist with food defense, food safety, and food surveillance.

Public health relevance
Public Health Relevance FOA-RFA-FD-15-019 Continued membership by our Residue Laboratory in the FDA/FERN/Chemical laboratory network is a significant capability for public health in terms of food defense and food safety for the country. As the FERN/Chemical network evolves and continues to become better as a result of increased training, experience, ISO accreditation, and instrument capabilities, the greater the benefit is to U.S. Public Health.